Age and hearing loss effects on subcortical neural encoding

PROJECT SUMMARY
Speech recognition difficulties are common for older adults and those with age-related hearing loss (ARHL),
particularly in complex environments. Maladaptive hyperexcitability in the central auditory system, a form of
central gain, is known to occur with age and hearing loss and may contribute to altered temporal processing
and subsequent speech-in-noise (SIN) deficits. Studies of central gain in humans often focus on cortical
hyperactivity, yet research suggests that subcortical hyperactivity, notably exaggerated encoding of sound
onsets and low-frequency amplitude modulation envelopes (like those common in speech), may be present in
the auditory midbrain of older and hearing-impaired adults and exert a larger influence on SIN difficulties than
previously thought. However, we currently lack a clear understanding of the contexts in which subcortical
hyperactivity exists in age and ARHL and how it relates to behavior. This complicates long-term efforts to
develop pharmaceutical and behavioral interventions to ameliorate SIN deficits. The overarching goal of the
proposed research is to characterize how hypersensitivities to stimulus onsets and modulation envelopes
localized to the auditory midbrain are (1) more prevalent for older than younger adults, (2) related to inferior
colliculus structure, (3) predicted by hearing loss in older adults (independently of age), and (4) associated with
SIN deficits. Experiments use an innovative combination of electrophysiology, structural neuroimaging, and
source localization to characterize neural responses arising from subcortical generator sites (e.g. inferior
colliculus) in both quiet and noise. To quantify hyperresponsivities in the midbrain relative to the periphery,
inferior colliculus responses are normalized auditory nerve responses. Aim 1 examines whether hyperactivity is
more prevalent in older adults relative to younger adults, whether diminished cochlear compression associated
with ARHL leads to enhanced envelope encoding in quiet, and assesses how midbrain microstructural
characteristics that have been associated with GABAergic changes (e.g. longitudinal relaxation time, R1) relate
to hypersensitivity and potentially mediate age effects. Aim 2 examines how midbrain hypersensitivity predicts
behavior, testing the hypothesis that greater hypersensitivity benefits perception in quiet (e.g., better amplitude
modulation (AM) discrimination in quiet) but not perception in noise (e.g., poorer performance on SIN tests,
poorer AM discrimination in noise). Results can advance our understanding of the contexts in which envelope
and sound onset hyperresponsivities are present in the subcortical auditory system, how best to quantify it, and
whether it alternately benefits or impedes perception. Findings will inform future studies of subcortical neural
hyperactivity and not only improve our understanding of SIN difficulties of older adults, but also determine the
extent to which clinical interventions need to consider declines in subcortical structure and function. With the
aging (and hearing-impaired) population growing yearly, this research has high

Public health relevance
PROJECT NARRATIVE Changes to auditory midbrain structure and function resulting from aging and age-related hearing loss may lead to neural hyperactivity and distorted neural representations of sound, which may underlie speech recognition difficulties. This project uses electrophysiology, neuroimaging, and behavioral methods to study the extent to which the auditory midbrain creates an exaggerated and atypical representation of the temporal features of sound, and whether this atypical representation is related to impaired speech recognition for older adults in challenging listening conditions. A better understanding of the extent to which neural hyperactivity and distorted temporal processing is present in the auditory midbrain of older adults and those with age-related hearing loss can inform future studies of subcortical neural hyperactivity and work towards improving speech communication outcomes.